ERα-initiated signals in the medial amygdala prevent stress-induced hypertension

DESCRIPTION (provided by applicant): This is an application for a Ruth L. Kirschstein NRSA for Individual Predoctoral Fellowship to Promote Diversity in Health-Related Research (Parent F31- Diversity) award for Antentor Othrell Hinton, Jr., a graduate student at Baylor College of Medicine. Hypertension (HTN) is the leading cause of cardiovascular disease worldwide and the number one killer in women. Interventions that treat and prevent HTN are urgently needed. Psychological stress contributes to development of HTN in humans, and these effects are mediated at least partly by neurons in the amygdala. In humans, mice and rats, neural activities in the medial amygdala (MeA) are positively associated with levels of blood pressure (BP) during stress and estrogens attenuate stress-induced c-fos expression in the MeA via estrogen receptor-α (ERα), yet the mechanisms remain unknown. Estrogen replacement therapy (ERT) lowers BP in postmenopausal women, but it also increases the risk of stroke and thromboembolism. It is the premise of this proposal that understanding specific pathways underlying the anti-hypertensive effects of estrogens may lead to novel and safer therapies for HTN. Here we hypothesize that ERα-initiated signaling pathways in MeA neurons prevent stress-induced HTN. In Aim 1, we hypothesized that ERα in the MeA mediates estrogenic effects to prevent stress-induced HTN. We generated sim1-ERα-KO mice, in which ERα is deleted mostly from MeA SIM1 neurons. Although estrogen replacement prevented stress-induced HTN in wild type ovariectomized (OVX) females, these effects were blunted in sim1-ERα-KO mice. To confirm these findings we will stereotaxically inject AAV-Cre (vs. AAV-GFP as a control) into the MeA of lox-ERα female mice. In Aim2, we found that central administration of a selective ERα agonist, propyl pyrazole triol (PPT), in female mice increased interactions of ERα and p85a (a regulatory PI3K subunit), and increased phosphorylation of AKT (a PI3K-mediated event) in the amygdala. This led us to hypothesize that PI3K in the MeA mediates estrogenic effects to prevent stress-induced HTN. To confirm these findings, we will stereotaxically inject AAV-Cre (vs. AAV-GFP as a control) into the MeA of lox-p110a female mice. In Aim 3, preliminary data suggest that central administration of PPT stimulates nitric oxide (NO) production in the amygdala via nitrate/nitrite assay. We will test if deletion of ERα i nNOS neurons (nNOS-ERα-KO mice) will blunt anti-hypertensive effects of E2 during stress and, rescue sim1-ERα-KO female mice using a NO donor. This proposal will teach us about the role of estrogens/ERα and MeA regulation in stress-induced HTN. Our studies will prove the concept that selective activation of MeA ERα can decrease BP, and therefore may identify a novel drug target for the treatment of HTN.

Public health relevance
PUBLIC HEALTH RELEVANCE: Estrogen replacement therapy lowers BP in postmenopausal women, but it also increases the risk of stroke. It is the premise of this proposal to understand the brain specific estrogen pathways that lead to preventing stress-induced hypertension. Advances in our understanding this brain specific estrogen target may lead to a novel or safer therapy for hypertension, especially for post-menopausal African American women.